Proteomic profiling of heart failure in Hispanics/Latinos

ABSTRACT
Heart failure (HF) cases are projected to increase steadily in the next decade given the aging population.
Inflammation is one pathophysiological feature of HF. Several direct anti-inflammatory therapies are designed
for HF; however, none has been proven to demonstrate convincing benefits. Hispanic Americans have high rates
of HF comorbidities, i.e., obesity and diabetes, key drivers of systemic inflammation, specifically for HF with
preserved left ventricular ejection fraction (HFpEF), a subtype without efficacious therapies. A few inflammatory
biomarkers have been identified reflecting HF comorbidities; the molecular pathways leading to cardiac
dysfunction, and ultimately HFpEF, are uncertain. Racial disparities have been observed in HF, however, data
from Hispanic/Latino populations are sparse. In addition, acculturation and socioeconomic factors can promote
inflammation, contributing to the abnormalities of cardiac structure and function. Lack of understanding of the
biologic pathways underlying cardiac dysfunction and development of HF is a critical barrier to developing
effective interventions to prevent HF, specifically in Hispanics/Latinos. We propose to perform state-of-art
proteome profiling in the NHLBI-sponsored Hispanic Community Health Study / Study of Latinos (HCHS/SOL),
the most comprehensive study of Hispanic/Latino health and disease to identify protein biomarkers associated
with cardiac dysfunction and HF risk. Our central hypothesis is that proteins, specifically reflecting systematic
inflammation, will be causally associated with cardiac structure and function, as well as the risk of HF. In Aim 1,
we will identify circulating proteins and protein signatures associated with impaired cardiac functions and their
progression. In Aim 2, we will identify circulating proteins and protein signatures that predict the development of
clinical HF. In both aims, we will further investigate the effect of identified protein signatures on acculturation,
socioeconomic and lifestyle factors. In Aim 3, we will identify genetic determinants of HF- and cardiac function-
related proteins, and determine the extent to which genetic variations relate to cardiac dysfunction and clinical
HF. With the completion of this project, we aim to generate insights into the biological pathways underlying
progressive cardiac dysfunction and HF, and to provide targets for drug development.

Public health relevance
NARRATIVE Abnormalities of cardiac structure and impairment of cardiac function precede the development of heart failure (HF) and underlie HF subtypes. To elucidate the proteomic determinants of cardiac dysfunction and HF, and to identify protein patterns that predict HF, will provide insights into the biological pathways underlying progressive cardiac dysfunction and HF and targets for drug development. Furthermore, to incorporate multi-omc data will enhance the understanding of plausible molecular pathways.